ARISEN (Autoimmunity, Rasmussen’s, Inflammation & Status Epilepticus research Network)

CLINICAL PROJECT 3: Project Summary
The goal of this project is to identify diagnostic biomarkers to aid in early diagnosis of autoimmune encephalitis
(AE), Rasmussen syndrome, and new onset refractory status epilepticus (NORSE). These are severe and poorly
understood neuroinflammatory conditions with high rates of morbidity and mortality. Mortality is high, with
residual neurological symptoms occurring in >80-90% of survivors. This is partly due to challenges in making a
timely diagnosis and lack of understanding of the underlying mechanisms driving disease leading to delayed or
inappropriate treatment. While differing clinical phenotypes eventually emerge over time, these syndromes can
initially present with similar neurological symptoms including altered mental status, behavioral changes, and
seizures, which can be particularly difficult to recognize in children. all three syndromes, the difficulty and
uncertainty in diagnosis leads to delays in initiation of immunomodulatory treatments which can lead to worse
outcomes. Treatment of these syndromes is also challenging, in part due to the lack of understanding of the
underlying inflammatory processes driving disease. Our long-term goal is to improve the diagnosis and treatment
of these diseases. The objective of this project is to explore the underlying immune mechanisms mediating AE,
Rasmussen’s, and NORSE with the goal of identifying key immune pathways that may differentiate these
diseases. Our central hypothesis is that while these diseases share some similar neuroinflammatory pathways,
there are underlying differences in both the proteome and transcriptome and novel autoantibodies that contribute
to disease. Our team, with expertise in cytokine analysis, CSF transcriptomics, and autoantibody discovery, is
exceptionally well qualified to test our hypotheses with the following aims: Aim 1 will identify blood and CSF
cytokine signatures that distinguish AE, Rasmussen syndrome, and NORSE. We will assess cytokine signatures
from serum and CSF at the time of presentation to identify differences and overlaps in inflammatory pathways
in AE, Rasmussen’s, and NORSE. Aim 2 will focus on identifying CSF host transcriptomic profiles that
differentiate between AE, Rasmussen syndrome, and NORSE. Although immune dysregulation likely contributes
to all three conditions, we hypothesize that the transcriptional profiles will differ given variable clinical
phenotypes. We will use bulk-RNA sequencing of CSF to identify similarities and differences in the host immune
response in these three diseases. Aim 3 will be to perform human proteome-wide antigen discovery on CSF
from patients with seronegative AE, Rasmussen syndrome and NORSE to identify novel autoantibodies that can
help better diagnose and sub-categorize patients. The impact of this project will be by leveraging cutting-edge
laboratory technologies, we will improve early diagnosis and expand our understanding of the underlying
inflammatory mechanisms driving AE, Rasmussen’s, and NORSE. Results of these studies will inform future
studies on treatment response, patient outcomes, and novel targeted treatments.